Establishing a Useful and Usable "Out of the Box" Quality Improvement Library for Enhanced Health System Efficiency and Outcomes

Project Abstract
Phrase Health is a clinical decision support (CDS) analytics company that empowers health systems to
efficiently incorporate scientific knowledge into high value clinical care through iterative, data-driven
improvements. CDS is a process for enhancing health‐related decisions and actions with pertinent, organized
clinical knowledge and patient information. While CDS has improved outcomes in sickle cell disease,
myocardial infarction, and many other diseases, its impact has been inconsistent. Continuous evaluation of
CDS is critical to achieve consistent improvement in outcomes, but evaluating CDS is burdensome for health
systems and often not performed. To address these challenges, Phrase Health developed a product called
Outcomes that offers a self-service guided walkthrough for quality improvement (QI) advocates of variable
experience levels to (1) rigorously evaluate the impact of CDS on clinical outcomes and (2) convert data-driven
insights into action. The approach has early market traction with advanced technical users. However, user
feedback cites a need for “out of the box” QI templates (defined as abstracted definitions for CDS
interventions, cohorts, measures, and their associations) to provide more structure and guidance. To address
this market demand with a high-value product, we will generate a library of “out of the box” QI templates that
target the inpatient management of diseases in the Hospital Readmissions Reduction Program (HRRP)
populated by both customer-generated content and ones authored by the study team.
In Aim 1, we will translate two clinical use cases already established by partner systems within our platform: (1)
inpatient management of pneumonia and (2) inpatient management of congestive heart failure (CHF).
In Aim 2, we will use our authoring platform to develop two de novo projects: (1) inpatient management of
chronic obstructive pulmonary disease (COPD) and (2) inpatient management of acute myocardial infarction
(AMI). We will calculate the time and costs associated with developing a new QI project template using our
authoring platform.
At the end of this project, we will have established the start of a library that translates clinical guidelines into
care delivery via “out of the box” QI templates for a set of diseases tied to significant financial incentives, but
also assessed the necessary investments required to scale to more disease templates. These data will begin
to address the market’s demand for accessible QI tools linked to electronic workflows and quantify future
investment needs, allowing us to commercialize and accelerate the translation of knowledge into better health
outcomes and support improved health system profitability in a value-based reimbursement environment.

Public health relevance
Project Narrative Clinical decision support (CDS) has the potential to improve patient outcomes by facilitating adherence to evidence-based practices, but it is burdensome to monitor and is oftentimes ineffective as a result. Phrase Health created Outcomes, a process evaluation web-based product to diagnose when and why CDS is not leading to the intended improvements. We are developing an “out of the box” library of quality improvement (QI) project templates for the Outcomes product for the inpatient management of pneumonia, congestive heart failure (CHF), acute myocardial infarction (AMI) and chronic obstructive pulmonary disease (COPD).